Building sustainable and innovative research in Cancer and Cardiovascular disease: Planning the design and development of the South American Center of Research Excellence to Counter NCDs (SACREN)

SUMMARY OF THE COORDINATING UNIT COMPONENT The Institute for Clinical Effectiveness and Health Policy (IECS) in Buenos Aires, Argentina will host the Coordinating Unit of SACREN. IECS has extensive experience in management, coordination, administration, financing, and data management of large, multicentric research studies at national, regional (Latin America),and global level (Asia and Africa). IECS will be in charge for overall operations and the executions of the Coordinating Unit and the Planning Unit aims, with the support of UPCH and DFCI. Dr Adolfo Rubinstein will be the PI in charge of the coordinating Unit. For this planning grant, the Steering Committee will be the primary decision making body, while the Director of SACREN, elected from one of the members of the Board of Directors , will be responsible for the implementation of activities. A Scientific Advisory board will provide expert support while an External Advisory Board will bring advice and strategic guidance to attain the goals of the center and promote community engagement We will leverage existing experience in web?based project management and collaboration tools as well as remote communication capabilities of SACREN partners to facilitate face?to? face and virtual meetings to enhance communication and project coordination. SACREN will ensure project operation through logistical support, administration, data collection, and data storage capabilities. The Coordinating Unit (CU) will also support collaborative research activities through effective communication and management, leveraging existing experience in web?based project management and collaboration tools as well as remote communication capabilities to facilitate face?to?face and virtual meetings, and enhance communication and project coordination. This Unit will also conduct a cancer research needs assessment and establish priorities informed by key stakeholders and community engagement, addressing cancer research knowledge gaps in South America. Finally, the CU will define performance indicators on individual and organizational achievements and strategies to ensure sustainability. The final output of the CU will be to deliver the strategic development plan to ensure continuity and sustainability of the center.

Public health relevance
PROJECT NARRATIVE OF THE COORDINATING UNIT COMPONENT The Institute for Clinical Effectiveness and Health Policy (IECS) in Buenos Aires, Argentina will host the Coordinating Unit of SACREN, which will ensure project operation through logistical support, administration, data collection, and data storage capabilities. The Coordinating Unit (CU) will also support collaborative research activities through effective communication and management. This Unit will also conduct a cancer research needs assessment and establish priorities informed by key stakeholders and community engagement, addressing cancer research knowledge gaps in South America. Finally, the CU will define performance indicators on individual and organizational achievements and strategies to ensure sustainability